BLRD Research Career Scientist Award Application

Dr. El-Rifai is a Research Career Scientist funded by a VA merit award since 2012. He is a member of the
Research and Development committee at the Miami VA who participates in active mentoring of junior scientists.
He is also the vice chair and Professor of Surgery, Leader of the Tumor Biology Research Program, and
Associate Director for Program Development at the University of Miami Miller School of Medicine and Sylvester
Comprehensive Cancer Center. As the Associate Director for Program Development at Sylvester, he works with
the senior leadership to create new research programs, including faculty alignment, recruitment and resource
allocation. Dr. El-Rifai oversees the research development, mentors junior faculty, and participates in research
training of residents and fellows. Dr. El-Rifai’s research is funded by VA merit awards since 2012 and continuous
NCI funding for 20 years with 197 peer-reviewed publications, and over 220 scientific abstracts. His research
aims for a better understanding of the biology of gastro-esophageal cancers and developing novel therapeutic
approaches. His laboratory provides unique training experiences in genetics, epigenetics, and cancer biology,
focusing on molecular mechanisms of gastrointestinal tumorigenesis and the development of novel strategies
for cancer therapeutics. Dr. El-Rifai has trained more than 75 personnel that included undergraduate and
graduate students, postdocs, and residents. He has mentored more than 15 junior faculty members, many of
whom have progressed to independent faculty positions. Dr. El-Rifai’s laboratory works closely with basic
science and clinical research colleagues for one common goal; a better clinical outcome. The El-Rifai laboratory
utilizes innovative mouse models, 3D organoid cultures, and human tissue samples. Dr. El-Rifai has made
significant contributions in the area of gastric cancer and esophageal adenocarcinoma. He has been successful
in identifying the signaling links between inflammation and cancer in gastric and esophageal adenocarcinomas,
discovering novel genes that mediate drug resistance, and developing targeted therapy approaches for upper
GI cancers. Dr. El-Rifai work using the trefoil factor 1 knockout mouse model in conjunction with in vitro assays
and human tissues samples has shown that TFF1 has potent anti-inflammatory and tumor suppressor functions,
which protect against the development of gastric cancer in mouse and human. Dr. El-Rifai lab has made
significant contributions to the current understanding of the molecular mechanisms underlying the development
of esophageal adenocarcinoma (EAC). Barrett’s esophagus, the main risk factor for EAC, develops as a
consequence of chronic gastroesophageal reflux disease. He demonstrated an epigenetic switch that turns off
several anti-tumorigenic antioxidant response genes, concordant with activation of other genes that promote a
pro-tumorigenic antioxidant response. The pioneering work from his lab has shown that DNA methylation wipes
out the expression of several protective antioxidant enzymes, important for protecting against reflux-induced
oxidative stress and DNA damage, thereby facilitating progression of metaplastic Barrett’s esophagus to EAC.
The pro-tumorigenic response included constitutive overexpression of redox factor 1 (REF1, also known as
APE1) and transcription factor NFE2- related factor 2 (NRF2), promoting DNA damage repair, oncogenic
signaling, and cancer cell survival Working with pharmaceutical companies, he tested novel targeted therapy
strategies and established MLN8237, alisertib, as a potent anti-cancer drug. MLN8237 is now listed on the NCI
Cooperative Research and Development Agreement (CRADA) and is studied in several clinical trials. Dr. El-
Rifai, working with medical oncology colleagues, has moved several concepts such as targeting AURKA and
mTOR into clinical trials. In summary, cancer is a disease with no boundaries; Dr. El-Rifai has a firm belief that
clinical and translational research founded on strong basic science discoveries is the way to win our battle
against cancer.

Public health relevance
Dr. El-Rifai research focuses on molecular studies of gastric cancer and esophageal adenocarcinoma (EAC). Gastric carcinoma is the third most common cause of cancer related-death worldwide. According to the World Health Organization, National Cancer Institute, and epidemiological data, individuals with chronic H. pylori infection carry a 3 - to-6 fold higher risk of developing gastric cancer. Recent studies of U.S soldiers deployed to the Middle East and Far East have shown that the incidence of H. pylori infection was 7.3 percent per year compared to 2.5 percent of U.S. military recruits living at home, which represents a major increase in risk. Furthermore, the incidence of gastroesophageal reflux disease, the main risk factor for EAC, is significantly higher in our veterans’ population than general population. Taken together, the molecular and translational research activities of Dr. El-Rifai lab are highly pertinent to our Veterans’ health.